Proteomics Core

Proteomics Core - Project Summary
This National Eye Institute-funded Proteomics Core aims to use modern technologies in the field of proteomics
to discover the causes and improve treatments for eye diseases, including cataract, glaucoma, retinal disease,
and corneal pain. Proteomic analyses will be performed with the specific aims of measuring changes in protein
abundance and modification with disease, determining how proteins fold and interact with one another, and how
they regulate development. The methods used will include tandem mass tagging to detect proteins undergoing
changes in abundance, phosphopeptide analysis to discover mechanisms controlling cellular processes, non-
restrictive searches to detect post-translational modifications, hydrogen-deuterium exchange and chemical
cross-linking to determine structure. The results will complement data generated by the other cores supported
by this P30 grant to increase the productivity of vision researchers at OHSU and devise better treatments for
eye disease. Dr. Lampi will continue in her role as co-Director, while addition of Dr. Reddy as co-Director will
broaden the reach of this core by providing increased support for experimental design, instrument operation, and
development of new sample preparation protocols.